DIABETES PREVENTION TRIAL--INTERVENTION/PARENTERAL

To determine whether early intervention with parenteral insulin therapy, consisting of periodic courses of intravenous insulin with accompanying chronic daily subcutaneous injections of long acting (ultralente) recombinant human insulin, will delay or prevent the development of clinical Type I diabetes. This intevention in the Experimental group will be compared with a standard group who will have close observation and early initiation of treatment at the first evidence of clinical Type I diabetes. We are following enrolled patients' progress and actively recruiting.